Improving diabetes outcomes and health disparities by addressing unmet resource needs- A Sequential Multiple Assignment, Randomized Trial

PROJECT SUMMARY
Multiple adverse social risks (e.g. food and/or housing insecurity, transportation challenges, social isolation)
and out-of-pocket, disease-related expenses are key reasons 1/3 of people with diabetes have high A1cs.
Through our CareAvenue mHealth intervention (R01DK116715), we enhanced our original intervention of
screening for social risks and connecting people with diabetes to resources by adding features for
observational learning, autonomy support, action planning, and self-monitoring. We observed low engagement
with the intervention and effectiveness for only 5% of participants. Social support interventions (e.g. peer
support, financial navigators, social workers) are more effective in addressing unmet social needs and self-
care challenges than stand-alone technology tools. However, these strategies are more resource- and labor-
intensive. Rather than dispensing the same fixed package of treatment components to all patients, an adaptive
approach can conserve resources by initiating autonomy-supportive treatment, and stepping up treatments for
those with suboptimal uptake. This R01 builds on the productivity, infrastructure, and investment of our prior
work to address key knowledge gaps for uptake of social care assistance to improve disease outcomes. The
overarching goal of this application is to identify what type of supportive components are optimal for addressing
unmet social needs and diabetes self-care, and which of five adaptive sequences of treatment results in better
outcomes. We will recruit 594 people with diabetes who have high A1cs, unmet social needs, and want
assistance with their needs. We will use a Sequential Multiple Assignment Randomized Trial (SMART) design
with 12-month follow-up to conduct this research. In Aim 1, we will determine which of five adaptive
intervention sequences is optimal for reducing A1c compared to social needs app only (usual care): 1) App +
peer support; 2) App + social worker; 3) App + technology-supported financial navigation; 4) App + peer
support + social worker; 5) App + peer support + technology-supported financial navigation. In Aim 2,
determine which of two augmented treatment adaptations is optimal for reducing A1c among non-responders:
social worker or technology-supported financial navigation. In exploratory Aim 2A, we will identify patient-level
moderators of treatment effect to inform personalized, resource-efficient protocols. In Aim 3, we will estimate
cost-effectiveness of five adaptive intervention sequences. We hypothesize that at 12 months, App + Peer
Support augmented with technology-supported financial navigation will produce superior outcomes (reduced
A1c, uptake of social care resources) relative to the 4 other adaptive interventions. The result of this SMART
study will be an optimized, adaptive intervention to improve the health and social wellbeing of people with
diabetes by determining the most effective intervention strategies.

Public health relevance
PROJECT NARRATIVE Unmet social needs and economic burden persist as key reasons why one-third of people with diabetes have poor disease control. Completion of our study aims will lead to an optimized intervention to improve the health and social wellbeing of people with diabetes. Findings will advance the field by determining effectiveness of supportive interventions to address both social needs and diabetes self-care and inform protocols for optimal sequencing of these strategies, a critical evidence-gap for healthcare settings.